PREGNANCY RISK ASSESSMENT MONITORING SYSTEM (PRAMS) SURVEY

The purpose of this agreement is to provide support to the CDC, National Center for Chronic
Disease and Prevention (NCCDPHP), Division of Reproductive Health (DRH), Women’s Health and Fertility Branch, Pregnancy Risk Assessment Monitoring System (PRAMS) Team to include a core question on disability among recently pregnant women in the PRAMS survey. At the request of the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD), National Center for Medical Rehabilitation Research (NCMRR), in fiscal year (FY) 2024 the DRH/PRAMS Team continues to complete mail, web, and phone survey document layout and data collection software and computerized assisted telephone interviewing (CATI) system programming and testing. During the period covered by this agreement, the DRH / PRAMS Team also agrees to complete data processing, including data weighting and prepare final analysis datasets for each site from which data on the new questions will become available to researchers to analyze.